IGF::OT::IGF DESIGNING METHODOLOGICALLY RIGOROUS ANIMAL STUDIES - XDA - EXPERIMENTAL DESIGN ASSISTANT. N44DA-16-1208. JULY 28, 2016 - JULY 27, 2018.

Under this Small Business Innovation Research (SBIR) Phase II project, Research Topic 154 for XDA - eXperimental Design Assistant the Contractor shall complete development of a platform to assist addiction and other life science investigators in designing in vivo animal experiments.